Biostatistics Module

Biostatistics - Project Summary
The VRC Biostatistics Core Module (BCM) supports consultation and collaboration in biostatistics and
epidemiology to Penn vision scientists. Biostatisticians provide advice on study design, sample size/power
determination, statistical analysis, data interpretation, and data presentation. They are also active participants
in the development and writing of grant applications and manuscripts. In addition to their methodological and
technical expertise, BCM personnel are very knowledgeable about ocular conditions (e.g., age-related macular
degeneration, glaucoma, myopia, retinopathy of prematurity, dry eye disease, uveitis) under study by Penn
vision researchers, about commonly used measures that are unique to vision research (e.g., visual acuity,
refractive error, visual field indices), about parameters derived from ocular images (e.g., retinal thickness from
OCT, retinal vessel width and tortuosity from Retcam images), and about specialized statistical analysis
techniques required for many experimental designs used in vision research (e.g., correlated data techniques to
handle appropriately data from two eyes of the same subject). An additional objective is to provide
bioinformatics support to access and analyze data from healthcare databases.